REDUCING OPIOID OVERPRESCRIBING BY COLLECTING PATIENT REPORTED OUTCOMES AND ESTABLISHING EMPIRICALLY-INFORMED STANDARD PRESCRIBING ORDER SETS.

The objective of this proposal is to develop a scalable system for reducing excess opioid prescribing by establishing right-sized prescription defaults for common surgical procedure based on patient reported postsurgical opioid usage.